JHU Center for the Advancement of HIV Neurotherapeutics (JHU CAHN) - Admin Core

PROJECT SUMMARY – ADMINISTRATIVE CORE
The JHU CAHN’s Administrative Core is the Center’s centralized hub that will be housed within the Johns
Hopkins University School of Medicine Department of Neurology. Its role is to support the operations of the
Center, which includes initiating communications across cores, offering researchers access to Johns Hopkins
institutional resources and Core facilities, oversee research activities with the Center, provide training and
mentoring opportunities, provide fiscal oversight, and continuous tracking of the productivity and impact of the
Center and its Core resources. This centralized Core provides a streamlined management infrastructure to
maximize efficiency and to integrate communications and informational resources to achieve Center utility, value,
and cohesiveness in support of research focused on developing novel treatments to mitigate the impact of CNS
complications in PWH. In addition to fiscal and managerial oversight, the Administrative Core will oversee all
JHU CAHN programs, initiatives, and policies including the funding and fiscal oversight of these activities. These
functions will be carried out by the Executive Committee that will manage disbursement of JHU CAHN funds to
the Cores and pilot grant awardees. The Executive Committee will also serve as the major liaison with the Johns
Hopkins School of Medicine with respect to institutional issues of space allocation to the JHU CAHN, support
and recruitment of faculty and staff affiliated with the JHU CAHN, and use of the Center’s Core resources. The
Executive Committee will coordinate responses to external sources on behalf of the JHU CAHN concerning
issues related to joint operations with affiliated NIMH NeuroHIV Centers, Hopkins affiliated investigators and
external investigators using JHU CAHN Core facilities. These include, collaborative research efforts with affiliated
NIMH Center investigators and trainees, skills-building and training workshops, or use of Core resources
including biospecimens and associated clinical and imaging data, or biomarker services. The Executive
Committee will be responsible for identifying high priority issues that are important for a response by the Center.
The Administrative Core will also oversee the award and fiscal management of pilot grants, the Pilot Award
Program, the weekly Joint NIMH Center Seminar Series and annual symposiums and other Center-focused
events.